Administrative Core

ABSTRACT For the past four years, the UW ALACRITY Center has served as a multidisciplinary incubator to
find viable solutions for improving the implementation of clinical interventions and implementation strategies
(CI/IS), using the Discover, Design and Build, Test Model to address challenges in CI/IS usability,
appropriateness and engagement. In the past 4 years, the center Administrative Core served to create
partnerships between different disciplines throughout the University of Washington, between researchers and
community settings, and to mentor early-stage investigators in careers focused on the use of CI/IS in
underserved settings. In these next five years, the Administrative Core, led by Drs. Lyon and Munson, will host
a multidisciplinary steering committee, a science and policy board, and a stakeholder board that will advise the
Center on research directions concerning CI/IS accessibility and effectiveness in the most common non-specialty
settings for adults and youth, respectively: primary care and schools. The administrative core has the following
aims: (1) Facilitate nimble, community-engaged translational research on the use of DDBT in the modification of
clinical interventions/implementation strategies (CI/IS) in primary care and school settings; (2) Foster synergy
among research disciplines and cores; (3) Request, review, and award pilot projects to multidisciplinary ESI
teams; (4) Support of early-career investigators through a monthly mentoring meeting and grant writer’s
bootcamp; (5) Evaluate Center progress in achieving goals and conduct strategic planning; and (6) Disseminate
Center activities and products. Special attention will be given to supporting the careers of ESI who are from
historically marginalized groups, and to teams who are truly multidisciplinary, such that the pilot studies will fully
benefit the career of each lead investigator. Dr. Fortney, who is internationally known for his multidisciplinary
research expertise and mentorship, will oversee the pilot program, and Dr. Areán, former UWAC director known
for her expertise in multidisciplinary research and mentorship of ESI from historically marginalized populations
will oversee the mentoring and grant writers bootcamp.
.